The Chicago Cancer Health Equity Collaborative (ChicagoCHEC)

Title: Enhancing Data Science Capacity at Northeastern Illinois University
Summary of the data science supplement for Northeastern Illinois University
(NEIU), MSI partner of the U54 ChicagoCHEC
Chicago's systemically underserved communities have disproportionately high
cancer rates. The Chicago Cancer Health Equity Collaborative (ChicagoCHEC) is a
comprehensive partnership between the two federally designated Hispanic Serving
Institutions, the University of Illinois at Chicago (UIC) and Northeastern Illinois University
(NEIU), and the Robert H. Lurie Comprehensive Cancer Center of Northwestern
University (NU-LCC). Dedicated to advancing cancer health equity through rigorous and
innovative science, education, and engagement of Chicago's underserved communities,
ChicagoCHEC relies on a nurturing hub of four Cores (Administrative, Planning and
Evaluation, Research Education, and Outreach) and a research project funding program.
This data science supplement has a primary focus on developing research,
educational, and outreach activities to increase the capacity in data science at NEIU, the
research-active, Minority Serving Institution (MSI) partner of the ChicagoCHEC initiative.
The proposed research activities in this supplement application complement and enhance
the overall ChicagoCHEC partnership goals. The education activities are centered around
development of new and adapting existing courses in data sciences for undergraduate
and graduate students at NEIU. Outreach activities focus on expanding partnerships with
underserved communities, specifically Chicago Public Schools in the immediate vicinity
of NEIU, and developing education programs using culturally appropriate education tools
about the importance of data science and its benefits.
As part of the ChicagoCHEC partnership, the goals of this data science
supplement application are centered within NEIU to build research capacity, strengthen
and expand NEIU's partnerships and develop new curriculum by training our faculty adopt
the data science initiative in their research and courses within the framework of cancer
disparities. We intend to achieve these objectives through three main aims including
establishing partnership with Metropolitan Chicago Data-science Corps (MCDC) and
organizing an informative workshop for NEIU faculty to learn and expand on their
expertise in data science resources and tools available to incorporate in courses and their
own research.
ChicagoCHEC will leverage the momentum forged by this data science
supplement to drive innovative cancer research, research education, and community
outreach and engagement that cuts across disciplinary and institutional boundaries.

Public health relevance
The relevance of the proposed data science supplement to public health is within the scope of the parent U54 ChicagoCHEC partnership. Specifically, this research will contribute to fundamental knowledge involving data science and cancer health-disparities to further enhance health, lengthen life, and reduce illness and disability of cancer patients in Chicago-land area and beyond.